PROTEIN REPAIR IN AGING VIA CARBOXYL METHYL TRANSFERASE

The overall goal of this project is to understand the molecular and cellular changes underlying the aging process by studying two abnormal forms of aspartyl residues in the protein, namely, L-isoAsp and D-Asp, and protein carboxyl methlytransferase (PCMT), a putative enzyme which repairs these damaged residue. Specific aims are: (1) to measure the levels of protein bound L-isoAsp and D-Asp in particulate fraction of human and rodent brain proteins as a function of age; (2) to determine the methyl accepting capacities of brain praticulate fraction for PCMT; (3) to purity paired helical filaments from Alzheimer brain and determine the ratio of D-Asp/L-Asp in the filament as a function of age; (4) to purify calmodulin and synapsin-1 from early adult and aged human brains and compare their methyl-accepting capacities for PCMT; and (5) to determine the PCMT isozyme patterns in human and rat brain as a function of age.